Core-Vision Processes

[unreadable] DESCRIPTION (provided by applicant): Five years of renewed support are requested for two core facilities in the Department of Brain and Cognitive Sciences at the Massachusetts Institute of Technology. Ours is a growing department which at present has 13 investigators who carry out research on vision, the visual system and the oculomotor system. Due to major support from the McGovern family and the Picower Foundation, two major new centers have been formed at MIT (the McGovern Institute for Brain Research and the Picower Center for Learning and Memory) in which numerous new appointments will be made the next five years, with several of them in vision and oculomotor control. Some of these appointments have already been made. Presently we have 12 grants from the National Eye Institute. The research carried out by the 13 investigators of the Core Group includes the following areas of research: (1) neurophysiological studies of the visual and oculomotor systems, (2) anatomical studies of the visual and oculomotor systems, (3) developmental studies of the vision and visuomotor function, (4) psychophysical studies of visual functions in non-human primates, (5) psychophysical studies of visual functions in normal human and patient populations, and (6) computational analyses of vision and eye movement. The two facilities supported by the Core Grant, the Instrument Shop and the Electronics Shop, are in extensive use by the Core Group. During the past four years these investigators have been very productive and have published extensively as documented in this application. The Core Facilities have made significant contributions to the overall research efforts of this group and have fostered interaction among investigators involved in vision and visuomotor research. Continued support of the Core Facilities will be of great benefit to our future investigations. [unreadable] [unreadable]